Novel Antagonists of the N-terminal Domain of the CRF Receptor Type 1 for Alzheimer's Disease

Project Summary/Abstract
CRF is the major neuropeptide hormone associated with stress and is mediated predominantly signaling
through CRF receptor subtype 1 (CRFR1) in the CNS. CRF signaling has been implicated in Alzheimer’s
disease (AD) as there is increased CRF expression, CRF binding to and upregulation of CRFR1 receptors in
the cortex, hippocampus and hypothalamus appears to occur early in disease AD progression and are
prominent neurochemical changes in areas vulnerable to AD neuropathology. CRFR1 expression also
intersects with Abeta (Aβ) and tau pathologies, both known to be critical hallmarks of AD. There have been
substantial efforts in academia and pharmaceutical companies to develop potent small molecule antagonists of
CRFR1, however, even the current 3rd generation antagonists are still directed against the C- terminal regions
of the CRFR1 receptor are still based on the 2nd generation chemical scaffolds along with their inherent toxicity
liabilities. This project capitalizes on the molecular model of CRFR1 activation, established through extensive
studies, where the first step is binding of CRF to specific ligand binding motifs in the receptor’s N-terminal
region and binding motifs. We have developed and validated an novel homogeneous TR-FRET assay to
measure the direct binding of biotin-labeled CRF to the N-terminal extracellular domain (ECD) of maltose
binding protein labeled CRFR1 compatible with very high-throughput screening. We have developed this
assay, verified that unlabeled CRF displaces biotin-CRF, and that several known C-terminal CRFR1
antagonists do not displace CRF from the N-term CRFR1 ECD. Motivated by these recent experiments, we
propose to screen a large library of compounds against N-terminal CRFR1 ECD in collaboration with the
Conrad Prebys Center for Chemical Genomics at Sanford Burnham Prebys Medical Discovery Institute.
In Aim 1, we will fully implement this primary N- terminal CRFR1 ECD assay and complete an HTS campaign
to identify and confirm candidate N-terminal CRFR1 antagonists. Aim 2 will validate these hits for potency,
specificity, functional antagonism and elucidate emergent structure activity relationships (SAR) to assess their
chemical tractability. Aim 3 will advance validated hits through hit-to-lead through cycles of medicinal
chemistry and testing through 2° critical path assays for potency and functional antagonism, then additional
lead optimization cycles where additionally, potency and efficacy in biologically relevant 3° assays for target
engagement (e.g. brain tissue slices). The best 2-3 probe compound(s), will be scale-up to benchmark their
ADME/T, PK/PD and brain penetrance and in vivo proof-of-concept studies in mouse AD models.

Public health relevance
Project Narrative Stress has been identified as a risk factor for developing Alzheimer’s disease (AD). Our work in animals has identified signaling through a major stress mediator, the type 1 corticotropin- releasing factor receptor (CRFR1), as contributing to the development of both defining hallmarks of AD pathology, β-amyloid (Aβ) plaque formation and tau phosphorylation/ aggregation. Here we propose to work with our colleagues at Sanford Burnham Prebys to develop new CRFR1 antagonists, directed at the CRF binding pocket in the N- terminus of CRFR1 as a means to mitigate manifestations of tau and Aβ pathology in animals models, and, if warranted, to extend the application to clinical trials in AD patients.